MEASUREMENTS AND METABOLISM OF NEUROSTEROIDS IN THE CENTRAL NERVOUS SYSTEM

The principal objective of this study is to determine the effect of ethanol on the metabolism of neurosteroids in the central nervous system. Neurosteroids such as 5a-pregnane-3a-ol-20-one (5a,3a-THP or Allopregnanolone) and 5a-pregnane-3a,21-diol-20- one (THDOC) have been shown to modulate the GABA/benzodiazepine binding sites and to exert anxiolytic and hypnotic effects. Modulation of these neurosteroids in the central nervous system by ethanol may be one of the underlying mechanisms for stress- related situations often observed in human alcoholics during withdrawal. In the past year, we have established a mass spectrometric technique which has adequate sensitivity to routinely measure trace levels of neurosteroids in cerebrospinal fluid(CSF). Specifically, GC/MS was used after derivatizing neurosteroids with an electron capturing moiety. Using this approach, we were able to detect pregnenolone, 5a,3a-, 5b,3a-, 5a,3b-THP, androsterone, testosterone, dihydrotestosterone and dihydroepandrosterone from human and monkey CSF samples. We found that human and monkey CSF contain both 5a,3a- and 5a,3b- THP at 5-170 picogram/ml concentrations while 5b,3a-THP is present at a concentration less than 5 pg/mL.